HEALTHY SUBJECT CELL COLLECTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To obtain mononuclear cells from healthy stubjects that will be used in other on-going research projects by the PI and other UCSD researchers